Phenotypic consequences of lipoprotein(a) in diverse populations

ABSTRACT
Lipoprotein(a) [Lp(a)], a highly atherogenic, prothrombotic, and proinflammatory lipoprotein, is a causal,
independent, and highly heritable {h2=70-90%) cardiovascular disease (CVD) risk factor that is elevated in 1.5
billion people globally. Despite significant stakes and emerging therapies that can reduce Lp(a) by >80%, few
overlooks opportunities to anticipate adverse effects of therapeutic Lp(a) lowering, illuminate mechanisms of
action, and identify novel treatment indications. A second major research gap is the Eurocentric evidence base
of Lp(a), which has persisted despite Lp(a) being recognized as one of the most variable CVD risk factors across
populations. This research gap constrains the generalizability, relevance, and reach of evidence that informs
Lp(a) clinical, regulatory, and public health decision making. A common factor underlying both research gaps is
the absence of validated Lp(a) measures in diverse studies with dense phenotypic data. We propose to address
this obstacle by assembling the largest and most ancestrally diverse {African, East Asian, European,
Hispanic/Latino, Polynesian, and South Asian populations) consortium with validated Lp(a) measures and
genotypic data. To further strengthen diversity, we will measure Lp(a) in African, Polynesian, and South
American cohorts using validated assays. Next, to facilitate causal inference in studies without measured Lp(a)
but with dense phenotypic data, we will leverage our diverse consortium and statistical genetics advances to
construct highly accurate Lp(a) polygenic risk scores (PRS) in all populations. These PRS will then be projected
into diverse biobanks with dense genotypic and phenotypic data, but no Lp(a) measures. Finally, we propose a
suite of causal inference studies that substitute Lp(a) PRS for measured Lp(a) and examine broad phenotypes.
These studies enable well-powered (n=993,708), comprehensive, and generalizable causal inference
investigations that are robust to confounding and reverse causation and examine broad phenotype classes. By
identifying and characterizing both the anticipated and unanticipated effects of Lp(a) in diverse populations, the
proposed study will provide an essential foundation for future efforts that aim to maximize the benefits and
minimize the risks of therapeutic Lp(a) lowering for everyone.

Public health relevance
PROJECT NARRATIVE Lipoprotein(a) [Lp(a)] is an independent cardiovascular disease (CVD) risk factor for which potent therapies are under evaluation. Despite significant clinical, public health, and regulatory stakes, the phenotypic landscape affected by Lp(a) remains largely uncharacterized, particularly in diverse populations with distinct Lp(a) distributions. Our assembly of the most ancestrally diverse Lp(a) study to date will offer crucial insights into the phenotypic effects of this emerging CVD risk factor, helping increase the generalizability, relevance, and reach of Lp(a) research in the 1.5 billion people globally with elevated Lp(a).